FUNCTION DURING AGING--ASSESSMENT OF PRIMATE AGING--CALORIC MODIFICATION

This project is attempting to determine whether caloric modification of the diets of rhesus and squirrel monkeys can affect aging rare as assessed by various physiological, biochemical and behavioral indices.